Administrative Core for SWOG SDMC

Project Summary/Abstract
Administrative Core
The SWOG SDMC Administrative Core is the home of the senior administrative leadership team of the SDMC;
it provides integration between the statistics and data management components. The senior administrative team
(in partnership with the SWOG Group Chair and NCI) sets priorities regarding the development of clinical trial
designs, monitoring, and data management for SWOG within the NCTN. The SWOG SDMC is located at the
Fred Hutchinson Cancer Research Center and Cancer Research And Biostatistics, which are both non-profit
research organizations.
The SDMC contributes to the collective management of the NCTN Program by participating in the NCI Scientific
Steering Committees, associated Task Forces, Working Groups, and other NCI initiatives. In addition, the
Administrative Core provides data from completed clinical trials in a timely and user-friendly format for public
access. The staff help in the interpretation of clinical data and facilitate the approved use of NCTN program
specimens archived by SWOG at the centralized biobank at Children's Nationwide Hospital.
SDMC faculty and staff have extensive collaborations with other NCTN Network Groups for the design, conduct,
and analysis of clinical trials. They also have significant collaborations with other NCI-sponsored programs,
especially the NCORP program.
The faculty contribute to new statistical methods developments for clinical trials design, data monitoring and
analysis, and genomic analysis, which is useful within the NCTN and also widely applicable to the greater cancer
research community. Areas of interest include new methods for precision medicine, immunotherapy studies, and
high-dimensional data analysis.